Methodological Approaches to Planning and Analysis of N*

Preparing for and responding to novel and re-emerging infectious diseases requires a range of mathematical models to: (a) understand and prevent the initial steps leading to emergence of a new disease from a purely zoonotic risk to human-to-human spread; (b) evaluate key parameters of the disease, including its reproduction number, serial interval, time course of infectiousness, etc. in the early phases of an outbreak; and (c) plan .inadvance for control measures, using models to compare the course of the epidemic (and its distribution) across various policies. In this grant, we will (a) develop models of control policies to minimize the spread of an infectious disease during the first cycles of transmission within humans, possibly before full human-to-human transmission is established; (b) develop tools for use in real time to estimate the reproductive number, effectiveness of control measures, and timing of infectiousness from the limited data available early in an outbreak; and (c) develop mathematical modeling tools that capture the key features of realistic disease transmission networks in models of intermediate complexity - less complex than full, individual-based simulation models but more complex than the simple differential equation models that fail to capture population structure. The goal of this work is to design tools that will aid in understanding and generalizing the output of computationally complex models of disease transmission.